Mentoring Clinical Investigators in Patient Oriented Research on Human Mobility and HIV

ABSTRACT
Human mobility plays a substantial role in driving the acquisition and transmission of HIV and
contributing to poor HIV care cascade outcomes. New evidence from large clinical trials shows that mobility
presents a major challenge to the successful implementation of well-recognized HIV eradication strategies
such as universal testing and treatment, as it can link geographically-spread epidemics, lead to introductions of
HIV into communities, reduce exposure to interventions, and disrupt HIV care engagement. There is an urgent
need to better understand the geospatial and temporal dimensions of mobility that lead to disparities in HIV
outcomes, and for feasible and scalable interventions to improve HIV outcomes in mobile populations. Yet,
research in these areas is nascent. There is a great need for an expanded scientific workforce with training in
human mobility and HIV to tackle these challenges, particularly for scientists under-represented in medicine.
Dr. Carol Camlin an Associate Professor in the Department of Obstetrics, Gynecology & Reproductive
Sciences at the University of California, San Francisco, and a behavioral scientist with training in social
demography. Her cross-disciplinary research program has focused on the study of human mobility and HIV
prevention and care outcomes. In this application for the Midcareer Investigator Award in Patient-Oriented
Research (K24), Dr. Camlin proposes a comprehensive mentoring, research and career development plan
which will advance the goal to reduce global disparities in HIV outcomes that result from human mobility.
The overall goals of this proposal are to: 1) Expand the scope of Dr. Camlin's POR in human mobility
and HIV through pursuit of training in geospatial and social network modeling methods, 2) Lay the groundwork
for conducting high-quality, large-scale, theory driven interventions to improve HIV care cascade outcomes
among mobile PLHIV in SSA; and 2) Engage fellows and junior faculty in the development of new
multidisciplinary POR to advance HIV prevention and treatment goals among mobile populations in Africa.
While the K24 provides limited resources for new research, with the support and protected time
provided by the K24, Dr. Camlin will be able to leverage the existing infrastructure of her current studies to: 1)
identify the geospatial networks of mobile populations and HIV “risk flows” in areas of Kenya and Uganda (Aim
1); 2) quantify the `distance decay' between clinics in origins and destinations of highly mobile persons living
with HIV (PLHIV) in the settings, and assess its influence on HIV care engagement (Aim 2); synthesize
cumulative findings and new developments in the field using an implementation science framework, and
convene a multidisciplinary panel of experts to review and prioritize promising interventions; and develop and
evaluate the potential feasibility, acceptability and appropriateness of two prototype strategies to improve HIV
care engagement among mobile PLHIV (Aim 3.) With K24 support, this project lays the groundwork for
sustained high impact research to address the challenges posed by mobility to efforts to eradicate HIV.

Public health relevance
Project Narrative There is an urgent need to better understand the geospatial and temporal dimensions of human mobility that lead to disparities in HIV outcomes, and for feasible and scalable interventions to improve HIV outcomes in mobile populations. Yet, research in these areas is nascent, and there is a great need for an expanded scientific workforce with training in human mobility and HIV to tackle these challenges. This application for the Midcareer Investigator Award in Patient-Oriented Research (K24) proposes a comprehensive mentoring, research and career development plan which will lay the groundwork for sustained, high impact research that is urgently needed to address the challenges posed by mobility to achieving HIV prevention and treatment goals.